Does the Addition of Cognitive Remediation to Coordinated Specialty Care Services Improve Functional Outcome?

Cognitive impairment is evident at first episode in most people with schizophrenia and is a key driver of
poor community functioning. Early intervention to reduce cognitive deficit has the potential to impact recovery
and quality of life. Cognitive remediation (CR) is an evidence-based behavioral skills intervention that directly
targets the cognitive processes underlying functioning in everyday life. Efficacy trials suggest that provision of
CR during an early stage of schizophrenia, and in the context of a rehabilitation program, results in greater
cognitive and functional gains than when it is provided later in the course of the illness and independent of a
recovery program. What is less clear is whether CR for first episode psychosis can enhance the outcomes of
coordinated specialty care (CSC), an evidence-based rehabilitation approach for people with recent onset
psychosis. Across CSC programs, about half of early psychosis consumers do not achieve vocational,
educational and/or social recovery. Adding CR to the menu of services could potentially improve these
outcomes but mechanism of CR delivery needs to be studied. It is unclear whether delivery of CR needs to be
done exclusively in the clinic with a clinician, or if some of the cognitive exercises can be done remotely and
independently. In this pilot research we aim to adapt an efficacious model of CR which is implemented in a
statewide system of care for adults with chronic mental illness, so as to optimize its feasibility and effectiveness
for people with early psychosis in CSC treatment settings. The hypotheses are that (1) adding CR to CSC
treatment as usual (TAU) will improve cognitive and functional outcomes, (2) delivering CR exclusively in-clinic
will yield better retention than delivering part of CR remotely, and (3) cognitive improvement is associated with
improvement in functional outcome. In Phase 1 (months 1-5), consultation with CSC experts will guide CR
adaptations to be developmentally and programmatically appropriate for use in CSCs treating an early
psychosis population. In Phase 2 (months 6-15), we will conduct an open feasibility trial (N=16) of the adapted
interventions in two CSC programs, one randomized to deliver CR exclusively in-clinic and the other
randomized to partial-remote delivery. Using data on acceptability, tolerability, treatment adherence, treatment
fidelity, and target engagement (i.e. change in cognition), we will make final adjustments to the intervention
content and structure. In Phase 3 (months 16-36), we will conduct a cluster randomized pilot feasibility trial of
the adapted CR interventions with 3 CSC programs providing TAU, and six programs providing TAU+CR,
either in-clinic (3 programs) or partial-remote (3 programs). The goal of this phase is to test the feasibility of the
adapted CR interventions and impact on functional outcome, compare impact of CR delivery methods on
treatment retention and effectiveness, and examine whether cognitive gains are associated with improvements
in functional outcome (e.g. work, school) for those receiving CR. These data will serve as a prerequisite to a
later, larger-scale intervention study of adding CR to the current array of CSC services for early psychosis.

Public health relevance
This study aims to adapt cognitive remediation for Coordinated Specialty Care and test whether improving cognition enhances gains in community functioning beyond those achieved by treatment as usual. The knowledge gained will inform the scope of evidence-based services needed to advance recovery outcomes following a first episode of psychosis, and therefore alleviate a significant public health burden.